Cancer Biology, Informatics & Omics (CBIO) Training Program

PROJECT SUMMARY
The Cancer Biology, Informatics & Omics (CBIO) program at the University of California, San Diego Health
Sciences (UCSDHS) trains PhD students and post-doctoral scholars in cancer research that emphasizes
discovery and application/development of informatics tools and omics technologies. The design of CBIO training
is driven by three rationales: (i) Basic research discoveries are essential to advancements in cancer diagnosis
and treatment; (ii) Cancer omics data combined with model organism research have accelerated the discovery
and analysis of novel cancer genes and pathways; and (iii) Investigation of cancer biology in the human system
requires proficiency in omics technologies and computational tools. The duration of each trainee appointment is
for two-years with the goal to (a) foster research excellence in advanced systems and approaches, (b) provide
foundational knowledge in cancer biology and bioinformatics, (c) develop translational insights through Tumor
Boards at the Moores UCSD Cancer Center, (d) keep pace with cancer research advancements through journal
clubs, seminars, workshops, and national conferences, (e) uphold scientific ethics, rigor and reproducibility
through coursework, workshops, refreshers and reinforcements, (f) develop trainee professional careers through
coursework, workshops and annual updates of myIDP plans, and (g) promote a collaborative community through
monthly scientific meetings and annual retreats. The CBIO program faculty conduct cancer research with
demonstrated productivity and expertise in diverse experimental systems. Besides biologists, biochemists and
geneticists, our faculty also include mathematicians and computer scientists working on the leading edge of
computational cancer research. CBIO faculty are held to the highest scientific standard and our senior faculty
each has a strong track record in training graduate students and postdoctoral scholars. CBIO and its predecessor
has had a successful track record in mentoring junior faculty, who bring new research and teaching expertise to
the program. CBIO has appointed 10 predocs/9 postdocs using the 3 predoc/3 postdoc slots awarded each year
and propose a continuation of 3 funded predoc and 3 funded postdoc positions in the next funding cycle. CBIO
trainees are PhD students and postdoctoral scholars with outstanding academic records and cancer-focused
research projects, selected from large pools of highly qualified candidates. The majority of our former trainees
are conducting research in academia, biotech, and pharmaceutical companies with others pursuing careers in
teaching, scientific writing and clinical practice. An Executive Committee of CBIO selects and evaluates trainees
and faculty with annual input from our External and Internal Advisory Committees. CBIO has added value to
research and education at UCSDHS by offering a new Cancer Genomics journal club, by organizing a new
training area on Computational Biology and Data Science in the Biomedical Sciences graduate program, and by
catalyzing collaborative research leading to new shared grant funding. Building on these successes, CBIO will
continue to serve as a hub for big data cancer research and education at UCSDHS in the years to come.

Public health relevance
PROJECT NARRATIVE The Cancer Biology, Informatics & Omics (CBIO) training program prepares the next-generation of scientists with the knowledge, skills and proficiency in designing and executing research that incorporates the collection, analysis and interpretation of large-scale omics data to investigate the complex biology of cancer and to drive further advancement in precision cancer medicine. CBIO has leveraged the outstanding research, teaching and technology-innovation environment at the University of California, San Diego Health Sciences (UCSDHS) to establish a program that adds value to trainee education, career development, faculty interactivity and computational biology research in the UCSDHS community. By building on its successes and with regular, formalized, program evaluations by External and Internal Advisory Committees, trainees and faculty, CBIO will continue to develop and streamline training activities to fulfill its mission as a catalyst of research education at the forefront of informatics- and omics-driven cancer research.